Stimulating Lymphocyte Activation Combined with Inhibition of Immunosuppressive Signals in Colon Cancer Metastases

Project Summary/Abstract
Colon cancer and colorectal liver metastases (CRLM) are a significant and lethal disease. Though there is a
strong scientific premise to harness the immune system to treat this cancer, there remains a fundamental gap in
understanding of how immunotherapies can be utilized, particularly microsatellite stable cancers. The central
hypothesis is that the tumor microenvironment can be manipulated to enhance cytotoxic lymphocyte infiltration
and activation, and that checkpoint blockade can be simultaneously utilized to incite a clinically relevant immune
response. This “one-two punch” hypothesis has been formulated on the basis of preliminary data wherein in-
creased T-cell trafficking to tumors, when combined with CTLA4 blockade, resulted in complete CRLM regres-
sions. The rationale for the proposed research is that once it is known how to enhance immunostimulatory signals
in the microenvironment and simultaneously suppress inhibitory influences, a new strategy for the management
of colon cancer is possible. This hypothesis will be tested by pursuing three specific aims: 1) Determine mecha-
nisms to enhance lymphocyte proliferation and anti-tumor specific immune responses in colon cancer by manip-
ulating immunosuppressive signals, 2) Examine mechanisms that supply immunostimulatory influences directly
into the tumor; and 3) Combine checkpoint blockade with selective delivery of human LIGHT to treat surgically
resected tumors and human CRLM in a pre-clinical autologous system. Under the first aim we expect to increase
lymphocyte infiltration, proliferation and activation while simultaneously curbing immunosuppressive signals/cells
in the microenvironment utilizing a validated pre-clinical model established by the applicants. In the second aim,
a clinically relevant method to safely increase LIGHT expression within colon cancer tumors using novel tumor-
specific viral delivery mechanisms engineered by the applicants will be analyzed. Under the third aim, patient
tumors will be utilized in an autologous humanized mouse model and treated with CTLA4 blockade combined
with oncolytic viral delivery mechanisms to increase LIGHT expression. Additionally, will test a mechanism to
deliver LIGHT in various formulations to therapeutic effect in CRLM through direct hepatic artery infusion (HAI).
This will be tested using 1.) a nanoparticle encapsulating LIGHT RNA and 2.) Ad-LIGHT. The proposed research
is innovative, because the multi-combination therapy of LIGHT expression in CRLM with tumor-specific oncolysis
and checkpoint blockade will deliver an inventive approach that will be universally applicable from patient to
patient. New horizons that will stem from this innovative strategy include a better understanding of anti-CTLA4
biology that may not only enhance response rates, but also vastly increase indications for its use in previously
“cold” tumors, including microsatellite stable gastrointestinal cancer. This contribution will be significant because
it will establish a synergistic combination of immunotherapies that will have direct translational impact on one of
the deadliest cancers worldwide. The implications of our results may improve patient quality of life and provide
survival advantages over the best current surgical and chemotherapeutic strategies for this disease.

Public health relevance
Project Narrative Over the last decade, colon cancer and CRLM have increased in young U.S. men and women resulting in a 1% annual increase in mortality. The proposed research is relevant to public health because the discovery of strategies to optimize anti-tumor immune responses in this dis- ease is ultimately expected to improve patient outcomes compared to the best current thera- pies. Despite the exciting results of immunotherapy and checkpoint blockade in many previously therapy-resistant malignancies, the field is currently stymied in how to utilize this technology to battle microsatellite stable (>95%) colon cancer, and, as a result, the proposed research is rele- vant to the NIH's mission to develop improved immunotherapy approaches of novel combina- tions to define how immunosuppressive tumor promoting environments can be overcome.